Feasibility and Effectiveness of Gamified Digital Intervention to Prevent Alcohol and Mental Health Risks

Project Abstract
Sexual minority women consume alcohol, experience alcohol-related problems, and suffer from mental
health problems at higher rates than do their heterosexual peers. Although several clinical programs are being
developed for sexual minority women (SMW) seeking treatment for these problems, only a small proportion of
SMW needing it ever seek treatment. Meanwhile, preventive interventions able to avoid these problems by
reducing drinking and improving psychological well-being among non-treatment seeking SMW have been slow
to emerge. The proposed research builds on R21AA025767, which established the preliminary feasibility and
effectiveness of delivering personalized normative feedback on drinking and coping behaviors to SMW within a
broader app-based social competition designed to challenge harmful stereotypes about this population and
foster a supportive virtual community. In our pilot trial, sexual minority women enthusiastically engaged with the
app in the absence of participation incentives for doing so. Further, relative to a sub-sample that received PNF
on control topics within the competition, those who received PNF on drinking and coping substantially reduced
their consumption and negative consequences over a 4-month period. Moreover, qualitative feedback
suggested that negative stereotype disconfirming PNF and social media inspired community features (present
across conditions) may have also provided psychological benefits beyond the alcohol and coping PNF
evaluated. To build on these promising findings and remedy limitations, this research proposes to first optimize
the app based on feedback from participants in the pilot trial (AIM1) and then conduct a large, sophisticated,
Type I implementation-effectiveness trial to simultaneously examine the effects of the fully featured app on
drinking, alcohol-related problems, and psychological well-being relative to a limited feature psychoeducational
control version of the app (AIM2), identify explanatory psychological mechanisms associated with the fully
featured app’s effectiveness (AIM3), elucidate demographic and sexual minority stigma-related moderators
(AIM4), and examine engagement, acceptability, and sustainability of use under real world conditions among a
sub-sample of unincentivized, fully featured app users (AIM 5).

Public health relevance
Project Narrative Sexual minority women disproportionately consume alcohol, suffer from alcohol-related problems, and experience depression and anxiety. Although clinical programs are being developed for sexual minority women seeking treatment, culturally tailored preventive interventions able reduce alcohol consumption and increase psychological well-being in the larger at-risk population not motivated to seek treatment have been slow to emerge. This project narrows the disparity in alcohol intervention research and practice by advancing a highly scalable, culturally adapted, gamified personalized normative feedback alcohol intervention able to engage non-treatment seeking sexual minority women and reduce their alcohol and mental health risks.